Improved flow cytometry panel design with a novel automated panel design system

PROJECT SUMMARY
Cytometry experiments are increasingly complex, often involving more than 20 unique parameters. For example,
the recent adaption of spectral flow cytometry means 64 or more channels with 40 simultaneous fluorescent
parameters currently validated in Optimized Multicolor Immunofluorescence Panels (OMIP)-069 have >31 million
combinations of commercially available products for these markers. Successful design of complex multi-param-
eter experiments requires extensive knowledge of panel design principles to organize antigens based on biolog-
ical density and cellular expression patterns. Insufficient user experience and poor panel optimization can lead
to errors in experimental design, resulting in unreliable, internally inconsistent data. These errors can cost thou-
sands of dollars and often waste rare or low-volume samples that may, in some cases, be irreplaceable. Recent
work has estimated that there is nearly $28.2 billion in costs associated with irreproducible preclinical work in
the U.S. alone that is predominantly attributed to poor antibody performance and study design. With the growing
complexity of flow cytometry experiments, there is a need for automated software that accelerates and optimizes
the experimental design process, reduces errors, and lowers the barrier to entry. With NIH Phase I support,
FluoroFinder completed initial development and demonstrated proof-of-concept for IntelliPanel, a highly custom-
izable tool for efficient and optimal design of flow cytometry assays that uses spectral overlap and biological
application information to automatically generate a flow cytometry assay for a given instrument configuration.
FluoroFinder developed the first version of IntelliPanel, conducted a comparison of autogenerated panels com-
pared to published OMIPS, and surveyed expert cytometrists to demonstrate 92% approval of IntelliPanel results
for up to 26 markers. In this Phase II project, FluoroFinder will integrate additional parameters, expand data-
bases, and generate user friendly tools that significantly improve the accuracy of IntelliPanel recommendations
for automated panels with 26 to 40 fluorescent markers and will advance features to improve standardization
and reproducibility in the field through the following Aims: Aim 1: Improve the automated ease-of-use and accu-
racy of recommendations through integration of the antigen density database and the expansion of additional
experimental parameters. Aim 2: Integrate a “Cell Type to Panel” feature to improve experimental reproducibility.
Aim 3: Optimize UX for comprehensive experimental recommendations based on user configuration. IntelliPanel
is expected to yield significant time and cost savings, reduce or eliminate design errors, and lower the barrier to
entry for developing successful flow cytometry experiments. Ultimately, these tools will enable the standardiza-
tion of assays, platforms and analysis that will lead to more consistent and reliable high parameter flow experi-
ments and emerging technologies (e.g., >26 color spectral flow cytometry).

Public health relevance
PROJECT NARRATIVE Flow cytometry is an essential tool in modern cellular and molecular biology, where the technique is critical in a variety of applications including the diagnosis of cancer and complex cellular assays in pharmaceutical develop- ment and medical research, amongst many others. However, the design and development of modern cytometry experiments is highly complex and error prone. In this project, FluoroFinder will advance development of the IntelliPanel to automatically generate reliable flow cytometry panels tailored to a user’s experimental and instru- ment configurations to yield significant time and cost savings, reduce or eliminate design errors, and lower the barrier to entry for developing successful flow cytometry experiments.